Improving Multicultural Engagement in Clinical Research through Partnership with Federally Qualified Health Centers and Community Health Worker Programs

SUMMARY:
It is critical to health equity to include people from different racial and ethnic communities as
clinical trial participants. Currently, there is a large difference in participation in clinical trials by
race and ethnicity with minority populations significantly underrepresented. Federally Qualified
Community Health Centers (FQHCS) are the largest network of primary care providers serving
underrepresented communities and research shows that providers must be part of successful
research participant recruitment. Additionally, FQHCs commonly utilize Community Health
Workers (CHWs) in these communities to increase engagement with the healthcare system.
Our proposed work looks to leverage this established infrastructure and trust at three diverse
FQHCs in North Carolina. Stakeholder feedback will be obtained through surveys and focus
groups and applied to the development of interactive curricula. FQHC providers and CHWs will
utilize these curricula to increase their awareness and acceptance of clinical trial participation
and allow them to disseminate knowledge to the communities they serve.

Public health relevance
NARRATIVE: Increasing the diversity of clinical trial participants is key to advancing health equity. This project aims to increase the recruitment of diverse participants in research through established provider and community health worker relationships in minority communities using new, interactive community driven curricula.